Community Partnership, Education, and Outreach Core

PROJECT SUMMARY – COMMUNITY, PARTNERSHIP, EDUCATION AND OUTREACH CORE
The Community Partnership, Education and Outreach (CPEO) Core will be driven by the Fibroid Foundation
under the leadership of founder and CEO Sateria Venable. The core will be supported by participation of Dr.
Sarah Rassier, MD MPH as well as Dr. Stewart, COEQUaL PD, and project leaders and co-investigators.
Importantly, the CPEO core will be more than a means to disseminate information from the research team to
the patient, research, and education communities; it will also be a conduit for these groups to express their
ideas, needs, and goals for ongoing and future fibroid research and avenues to close persistent historical
disparities gaps that lead to health disparities for Black/African American women with uterine fibroids. This
ability to synthesize community feedback will be an essential element of a thriving, responsive COEQUaL
program, one ready to listen to its constituents. The Fibroid Foundation, with its more than 50,000 members, is
well-positioned to be the optimally engaged partner in the success, evolution, and growth of the CPEO Core
and COEQUaL program in its entirety.